Bioinformatics and Biostatistics Core

SUMMARY FOR CORE D
The Bioinformatics and Biostatistics Core D will provide bioinformatic and biostatistical services and support data
analyses for all Projects. Core D will be situated at the Icahn School of Medicine at Mount Sinai and led by Dr.
Li Shen, who is an expert in bioinformatics and machine learning applications. One of the Core’s tasks is to
support multi-omics and integrated analysis. The pre-clinical and clinical studies in Projects 1, 2, and 4
will leverage multi-omics technologies to profile systemic stress-related immune dysregulations at the cellular
and molecular levels. The Core has dedicated bioinformaticians to aid PPG researchers in analyzing,
visualizing, and mining data from transcriptomics, epigenomics, and proteomics experiments in various
animal models (Projects 1 and 2) and patients (Projects 2 and 4). The Core will leverage state-of-the-arts
bioinformatic tools and machine learning methods for robust, efficient and integrated analyses of the
multi-omics and related phenotypic data. The Core will also provide comprehensive biostatistical support.
Statistical issues will be addressed at all investigatory levels, from designing experiments to interpreting
results and forming conclusions. Clear distinctions will be made between conclusions based on formal
hypothesis testing and important leads discovered by data exploration. Lastly, the Core aims to reduce
biases, enhance reproducibility, and share data and code with the scientific community. The Core will make
every effort possible to reduce potential biases in the statistical analysis. Multiple testing correction will be
performed on all omics data. The Core will also share the sequencing and secondary data derived from raw
images to the public. Software tools developed by the Core will also be shared as open-source projects.